Development of a radiation countermeasure with sex-dependent radiation response.

PROJECT SUMMARY/ABSTRACT
The research goal is to understand the mechanism underlying sex-specific effects in the regulation of radiation
response and to develop a novel radiation countermeasure that targets such differences. Radiation responses
can vary between sexes. Women have a higher long-term risk of radiation-induced cancers than men. However,
female mice reveal greater resistance to radiation and exhibit stronger short-term protective responses. Such
differences in humans and rodents underscore the necessity for further research to uncover the underlying
mechanisms and their implications for radiation biology and medicine. Radiation countermeasures are designed
to reduce damages. Despite extensive research, only a few have received FDA approval. Challenges persist in
addressing long-term radiation effects and understanding sex-related responses. Our published and preliminary
studies showed female Lxn knockout (Lxn-/-) mice had increased hematopoietic stem/progenitor cell (HSPC)
survival and regeneration in physiological condition by downregulating thrombospondin 1 (Thbs1). Lxn deletion
enhances radiation-induced survival by mitigating hematopoietic-acute radiation response and delayed effects
by upregulating Bcl-2. Surprisingly, the male Lxn-/- mice had no hematopoietic changes in physiological
condition, which is mechanistically due to the sex-specific silence of Thbs1 gene expression. We screened a
novel Lxn inhibitor that shows radiation mitigation effect in vitro and in vivo in female mice. We hypothesize that
pharmaceutical and genetic inhibition of Lxn mitigates radiation injuries in a sex-dependent manner. Two aims
will be proposed. Aim 1 is to determine the cellular and molecular mechanisms of Lxn deletion in radiation
mitigation in male mice. Aim 2 is to determine whether Lxn inhibitor is a countermeasure with sex-specific
radiation mitigation effect. The results will advance our understanding of the mechanisms underlying sex-specific
regulation of radiation response and produce significant implications for accurate radiation risk assessments and
targeted treatments in various radiation exposure scenarios.

Public health relevance
PROJECT NARRATIVE Radiation responses differ between sexes. Radiation countermeasures treating sex-specific radiation responses are lacking. This study is to better understand the sex-specific effects of latexin on radiation response regulation and to develop a novel latexin-target countermeasure with potential sex-specific pharmacological responses.